Mechanism of chromatin accessibility, 3D chromosome organization, and their functions in gene regulation

Project Summary/Abstract
The overall theme of my research program is to understand the formation mechanism of chromatin structure
and its role in gene regulation. We plan to address this problem at two different levels: 1) at the
chromatin / nucleosome level, we will identify pioneer factors (PFs) and investigate the mechanism underlying
nucleosome displacement and chromatin opening, and 2) at the chromosome level, we will study the
mechanism of gene regulation by high-order 3D chromosome organization. In the past five years,
supported by two NIGMS R01 grants, we have made significant progress in both directions. New
observations and insights we gained from these studies, as well as several novel methods we developed,
form the foundation of this proposal.
Theme1: Pioneer factors (PFs) can invade nucleosome and increase chromatin accessibility near their binding
sites and therefore play critical roles in gene regulation. Mis-regulation of PFs is highly linked to cancer
and developmental disease. Despite their essential functions, only a handful of PFs have been identified
and the mechanism underlying the pioneer activity is unclear. The long term goal of this theme is to
systematically characterize PFs and their pioneer activities in health and disease cells, and to develop a full
understanding of the mechanism of these activities. In our recent PF studies, we have innovated an
Integrated Synthetic Oligo (ISO) assay to investigate PF function in a high-throughput manner. In the next five
years, we plan to 1) adapt the ISO assay into human cell lines and pluripotent stem cells to dissect the genetic
rules underlying PF binding and nucleosome displacement, and 2) further our understanding of the pioneering
activity by investigating the co-factors of PFs, the sequence of events during nucleosome displacement, and
the kinetic rates of these events.
Theme2: Imaging and 3C-based methods have revealed 3D chromosome organization with extensive
long-distance chromosomal interactions. The long-term goal of this theme is to understand the formation
mechanism of these high-order chromosome structures and their roles in gene regulation. Our recent studies
show that long-distance chromosomal interactions contribute to gene regulation in yeast. More specifically,
some allelic or co-regulated genes cluster in the 3D space, and such clustering is correlated with higher gene
activities. The former case is analogous to the “transvection” phenomenon in Drosophila. These novel
observations revealed a new layer of gene regulation in yeast and opened the opportunity of using the
powerful genetic system to investigate the 3D genome function. Currently we have little understanding of what
mediates the cluster formation and how the clusters enhance gene expression. In the next five years, we plan
to 1) use an unbiased genetic screen to identify factors that negatively regulate transvection, and investigate
the underlying mechanism, and 2) test the hypothesis that some activators condense though liquid-liquid
phase separation, leading to the clustering of co-regulated genes and enhanced expression.

Public health relevance
Project Narrative One of the major focus of the parental grant, R35 GM139654, is to study the mechanism and function of pioneer factors (PFs). Pioneer factors (PFs) can invade nucleosome and increase chromatin accessibility near their binding sites and therefore play critical roles in gene regulation. Mis-regulation of PFs is highly linked to cancer and developmental disease. Despite their essential functions, the mechanism of nucleosome invasion by PFs and their function in gene regulation require further elucidation. My lab has been developing methods to study PFs in budding yeast for many years, and we recently extended our research into human cells. Here, we request funding to purchase an -80C freezer that will be used to store mammalian samples. This equipment will fulfill a critical need for my lab, as well as the Center of Gene Regulation at Penn State, which my lab is part of.